Transitions in the acquisition of language in kids with Down Syndrome

Abstract
With a prevalence of 1 in 691 live births, Down syndrome (DS) is the leading genetic cause of intellectual
disability. Nonetheless, our understanding of the nature and development of the DS phenotype, including in the
area of expressive communication (EC), has lagged relative to other neurodevelopmental disabilities. Despite
the ubiquitous nature of EC delays in DS, significant variability is observed across children in the nature of these
delays. Most EC research approaches in DS have focused on group-level performance, involved small sample
sizes, and used either cross-sectional designs or sparse longitudinal sampling (e.g., 1-year or more observation
intervals) to characterize development. These approaches mask within-group variability and cannot identify
subtypes based on their developmental trajectories, hampering the implementation of individualized treatment
options. Research that translates deep-phenotyping methods into clinically meaningful assessments is crucial
for elucidating the variability observed among children, identifying the factors producing this variability, and
improving our ability to anticipate developmental patterns. In turn, such data will support the development of
high-impact clinical practices better matched to individual children’s needs. In this project, we propose a 3-year
longitudinal investigation of EC development in 180 children with DS from 18 to 54 months of age that uses
deep-phenotyping and dense-sampling methods collected in-person and via telehealth monitoring that enhances
understanding of the variability, nature, and timing of clinically meaningful EC indicators. Utilizing these
procedures, we will be able to (1) characterize individual differences at study entry, (2) use deep-phenotyping
and dense longitudinal sampling to characterize heterogeneity and developmental changes in EC skills, and (3)
characterize heterogeneity and development across clinically meaningful indicators of major EC changes. This
multi-method, dense sampling approach will allow us to significantly improve our ability to monitor EC progress
over time in children with DS and improve our prediction of developmental patterns, thereby enabling the future
creation of personalized pathways for early assessment and intervention.

Public health relevance
Project Narrative Despite the ubiquitous nature of EC delays in Down syndrome (DS), significant variability is observed across children in the nature of these delays. Most EC research approaches in DS have used research designs that mask within-group variability and cannot identify subtypes based on their developmental trajectories, hampering the implementation of individualized treatment options. We propose a three-year longitudinal investigation of EC development, using a multi-method, dense sampling approach that will allow us to significantly improve our ability to monitor EC progress over time in children with DS and improve our prediction of developmental patterns, thereby enabling the future creation of personalized pathways for early assessment and intervention.